Developing and Testing a Tool for Preference Elicitation in Carpal Tunnel Syndrome

Abstract
This is an application for a K23 award to Dr. Kamal, an Assistant Professor in the Department of Orthopedic
Surgery at Stanford University. Dr. Kamal is establishing himself as an investigator in patient-oriented research
focused on preference elicitation in carpal tunnel syndrome. This K23 Award will provide Dr. Kamal the support
necessary to complete the following goals:
1) to become skilled in patient-centered outcome research utilizing conjoint analysis for preference elicitation
2) to conduct clinical investigation of patient preferences in carpal tunnel syndrome
3) to learn and apply rigorous qualitative and quantitative methods in clinical studies
4) to develop the leadership and managerial skills needed to be an independent investigator
5) to develop into a national leader in quality in hand surgery
To achieve these goals Dr. Kamal has assembled a team of mentors comprised of the following: Dr. Laurence
Baker (Chair, Dept. of Health Research and Policy, Stanford School of Medicine), Dr. Arden Morris (Vice-Chair
Clinical Research Dept. of Surgery, Stanford School of Medicine, and Dr. Alex Harris (Associate Professor,
Dept. of Surgery, Stanford School of Medicine).
We aim to 1) develop a patient-derived database of attributes important to patients being treated for carpal
tunnel syndrome; 2) create a conjoint analysis tool for preference elicitation at point of care of carpal tunnel
syndrome; 3) test the tool on patient decisional conflict. This research will create a preference elicitation tool
that could serve as the foundation of an R01 grant to study the broad effects of preference elicitation
approaches on decision making and patient-centered outcomes in carpal tunnel syndrome, and other upper
extremity conditions.

Public health relevance
Narrative Patients with conditions that do not have a clear “best” treatment, such as carpal tunnel syndrome, should make their treatment decision based on what is important to them (i.e. their preferences). There is currently no process for patients to identify what's important to them when deciding treatment for carpal tunnel syndrome. We will build a tool for patients to use when they see their doctor for carpal tunnel syndrome that will help them identify what's important to them.